GenomeTrakr: Preventing foodborne illnesses via an integrated food safety system

PROJECT SUMMARY
The South Dakota Animal Disease Research and Diagnostic Laboratory at South Dakota
State University will develop and coordinate a routine environmental sampling program
within university production facilities of dairy products, cereal grains, seeds, and legumes.
All samples will be cultured for 3 priority foodborne bacterial pathogens (Salmonella spp.,
Cronobacter spp., and Listeria monocytogenes), sequencing any pathogens isolated. The
sequencing data will be uploaded to NCBI with appropriate metadata.

Public health relevance
PROJECT NARRATIVE – OVERALL This project will test samples collected from human and animal food production sites in South Dakota and determine presence of foodborne pathogens. Bacteria isolated from these environments will be sequenced and data will be shared via public database.